PROTEIN-CALORIE THERAPY PLUS ANABOLIC STEROIDS IN ALCOHOLIC HEPATITIS

The purpose of this study is to evaluate protein-calorie therapy in combination with anabolic steroids in the treatment of moderate to severe alcoholic hepatitis with respect to long-term survival, disease complications nutritional parameters, liver histology, and biochemical features of the disease.